Neuronal Regulation of Vascular Development and Maturation in the Retina

PROJECT SUMMARY
Reciprocal interactions among neuroglial and vascular components in the developing postnatal retina are
critical for proper vascular development (angiogenesis) and maturation [establishment of the blood-retina
barrier (BRB)]. Although neuronal or glial cell-derived signals that promote angiogenesis and BRB maturation
are being elucidated, we still do not understand: a) how neuronal activity and b) which specific
neurotransmitter(s) influence these processes; and c) whether neurotransmitters act on endothelial cells (ECs)
directly or indirectly, via astrocytes or Müller cells. The superficial plexus vasculature develops during the
spontaneous cholinergic wave of neural activity and photoactivation of Opn4+ retinal ganglion cells (RGC) (P1-
P9). In contrast, the deep plexus vascular development and BRB maturation span both cholinergic and
glutamatergic waves of neuronal activity (P10-P14), glutamatergic synaptic activity of photoreceptors as well
as photoactivation of Opn4+ RGCs. Transient pharmacological blockade of cholinergic waves delays deep
plexus angiogenesis and BRB maturation; however, the role of extracellular glutamate in these processes is
unknown. In preliminary studies, we have used two mouse strains to assess the effects of glutamate release
on retinal angiogenesis and BRB maturation: a) Vglut1 -/- mice that lack glutamate release in the synaptic cleft
and b) Gnat1-/- mice, in which rod photoreceptors lack the phototransduction machinery and remain
depolarized, thus releasing excess glutamate. We have found that neuronal activity-dependent glutamate
release is a positive regulator of deep plexus angiogenesis and BRB maturation. These effects are mediated
by induction of Norrin expression in Müller glia and Norrin/b-catenin pathway activation in ECs. Based on these
preliminary data, we hypothesize that extracellular glutamate levels are sensed by Müller cells, which in turn
operate as transducers to induce expression of angiogenic and BRB-forming factors and promote deep plexus
angiogenesis and BRB maturation. We will test this hypothesis through three aims. First, we will examine how
modulation of extracellular glutamate levels [Vglut1-/- mice (no glutamate release) and Gnat1-/- mice (high
glutamate release)] regulates retinal angiogenesis and structural and functional BRB integrity in the developing
retina. Next, we will test whether Müller cells sense extracellular glutamate levels and respond by inducing
expression of angiogenic and barriergenic factors. We will examine Müller cell responses [cell number,
expression of GLAST (Slc1a3; a major glutamate transporter), glutamine synthetase (an enzyme responsible
for converting glutamate to glutamine) and Norrin (an angiogenesis factor expressed by Müller cells)] in Vglut1-
/- and Gnat1-/- mice. Finally, we will test if activation of Norrin/b-catenin signalling, that promotes angiogenesis
and BRB maturation, in ECs can rescue deficits of Vglut1-/- mice. These studies will provide a mechanistic
understanding of how glutamatergic synaptic activity regulates vascular development and maturation in the
retina and elucidate how glutamate excitotoxicity affects blood vessels in neurodegenerative retinal diseases.

Public health relevance
PROJECT NARRATIVE Although metabolic demand from neuronal function has been shown to regulate vascular development in the retina, a detailed mechanistic understanding of how neuronal activity influences angiogenesis and blood-retinal barrier maturation remains unknown. This project will explore how cholinergic and glutamatergic neuronal activities (separately or in combination) regulate retinal angiogenesis and blood-retinal barrier maturation using genetic, molecular and imaging approaches. The knowledge gathered from this project may be of critical importance to understand the pathophysiology of retinal diseases associated with neurodegeneration and develop novel therapeutic interventions for their treatment.